Mechanistic Studies on Meprin Metalloproteases and Meprin-Substrate Interactions in Tissue Injury

PROJECT SUMMARY/ ABSTRACT. My research program focuses on understanding the cellular and molecular mechanisms underlying the progression of tissue injury mediated by meprin metalloproteases. Meprins comprise of two subunits, α and β, which form two protein isoforms, meprin A (α-α or α-β) and meprin B (β-β) with distinct and overlapping substrates. Meprins are most abundantly expressed in the brush-border membranes of proximal kidney tubules and small intestines. Meprins are also expressed in leukocytes (monocytes and macrophages), podocytes, skin, endothelial cells, and cancer cells. Meprins have been implicated in the pathophysiology of inflammatory- and fibrosis-associated diseases that include kidney disease, inflammatory bowel disease, lung fibrosis, neurodegenerative disease (e.g. Alzheimer’s disease), and cancer. Single nucleotide polymorphisms (SNPs) in the meprin β gene were shown to associate with severity of certain diseases such as diabetic kidney disease and cancer. My research group uses a combination of molecular biology and proteomic approaches to identify meprin substrates and characterize the interactions between meprin isoforms and their substrates. These are coupled with in vivo studies with meprin knockout mouse models to determine how meprin activity impacts the progression of disease. Known meprin substrates include extracellular matrix (ECM) proteins, modulators of inflammation (e.g. proinflammatory cytokines [IL-1β, IL-6, IL-18, MCP-1; and anti-inflammatory proteins Ac-SDKP), cell signaling proteins (e.g. protein kinase A and protein kinase C), mediators of the hypoxia response (e.g. osteosarcoma-9), tight junction proteins (e.g. claudin 5, occludin, E-cadherin, and Z0-1) cytoskeletal proteins (e.g. villin and actin) and proteins that contribute to plaques in AD (e.g. amyloid precursor protein and triggering receptor expressed on myeloid cells 2). The diversity of meprins substrates suggests that complex mechanisms are involved under different conditions and in different organs. It’s important to gain understanding of these mechanisms to facilitate development of diagnostic and therapeutic tools. For the five year period of this proposal, we will conduct studies in three areas; (i) to determine how SNPS in the meprin β gene impact its interactions with substrates and physiological sheddases, (ii) determine how meprin interactions with substrates modulate signaling pathways and impact responses in hypoxia, inflammation, and ECM metabolism, and (iii) to evaluate the use of meprin and meprin cleavage products as biomarkers for development of diagnostic tools for early detection of disease. The proposed research will transcend basic (in vitro and in vivo) to gain insights on the basis for genetic predispositions associated with meprins. Translational studies are also proposed to apply this knowledge in development of diagnostic tools applicable to diabetic kidney injury and Alzheimer’s disease (AD), an important step in advancing precision medicine. Furthermore, this award will facilitate mentoring of trainees at various career levels, including undergraduate and graduate students as well as postdoctoral scholars, thus advancing biomedical workforce development.

Public health relevance
PROJECT NARRATIVE. Meprin metalloproteases have been implicated in the pathophysiology of chronic kidney injury induced by diabetes and neurodegenerative disease (e.g. Alzheimer’s disease). The proposed research program will determine; (1) how single nucleotide polymorphisms (SNPs) in the meprin genes impact interaction between the meprin enzymes and their substrates, (2) how cleavage of meprin substrates influence signaling pathways involved in disease progression, and (3) the potential use of meprins and meprin cleavage products in early diagnosis of tissue injury. This knowledge is important in developing therapeutic targets and diagnostic tools for diseases such as chronic kidney injury and Alzheimer’s disease.